Mechanism of DNA replication initiation in Saccharomyces cerevisiae

Summary
DNA replication stress has been recognized as a major source for the genome instability associated
with numerous diseases, including cancer. Therefore, understanding the molecular basis of replication
stress and, conversely, how accurate, complete, and rapid chromosomal DNA replication is achieved during
normal cell proliferation, is crucial for understanding the mechanisms that maintain or threaten genome
stability during normal development and disease, respectively. Here we propose experiments that will
illuminate both the intrinsic mechanism of the eukaryotic DNA replication machinery and its response to
diverse replication stress conditions. In the previous grant cycle we have generated a fully reconstituted
origin-dependent DNA replication system based on purified budding yeast proteins. This system forms the
central platform for research in our lab over the next funding cycle. In Aim 1 we will exploit the unique
biochemical tractability of this system to elucidate the mechanism of the eukaryotic replicative DNA helicase,
CMG (Cdc45-Mcm2-7-GINS), which is at the center of the replisome. The CMG is unique among replicative
DNA helicases from the three domains of life in that its helicase motor, the Mcm2-7 complex, is composed
of 6 distinct subunits. The reasons for this complexity are still obscure. Intriguingly, we have identified a
previously unrecognized essential role for the unique unstructured N-terminal tail of Mcm2. Our preliminary
data indicate that this domain is involved in multiple functions at the replisome, including DNA unwinding,
priming, and chromatin replication. We propose to characterize the unexpected functional versatility of this
helicase domain as a gateway to the elucidation of the intrinsic mechanism of a eukaryotic replisome. The
focus of Aims 2 and 3 will be to expand the basic DNA replication system for the study of DNA replication
stress mechanisms. Experiments in Aim2 build on our original reconstitution of unidirectional replisome
collisions with R-loops, a co-transcriptionally formed nucleic acid structure that has been recognized to pose
a major threat to genome stability in all organisms. We find that R-loops form an intrinsic barrier to
replisome progression by creating a physical block to the fork. A large number of proteins, such as
helicases and RNase H-type nucleases, have been implicated in promoting DNA replication in vivo by
resolving R-loops. However, the mechanisms are largely unknown. We have purified these accessory
enzymes and will characterize their role in promoting fork progression through R-loops. The basis for Aim 3
is our observation that dNTP depletion, one of the most-studied forms of replication stress, causes
uncoupling of replisome progression from DNA synthesis in the reconstituted system. We use this reaction
to investigate the mechanism by which the checkpoint regulates stalled fork stability, focusing on the central
checkpoint effector kinase, Rad53.

Public health relevance
Project narrative Each time a cell divides it must produce accurate copies of its chromosomes by replicating the chromosomal DNA and its associated chromatin structure. This process is essential and defects in chromosome replication can lead to mutations, chromosomal rearrangements and cancer. This project will generate novel assays and tools for the study of chromosome replication in vitro and elucidate molecular mechanisms that ensure chromosome replication fidelity under normal and replication stress conditions.